ASSESSMENT OF HYDROGEN PEROXIDE GENERATION IN NEUTROPHILS BY FLOW CYTOMETRY

Develop and apply an assay for evaluating hydrogen peroxide production by human neutrophils following stimulation using flow cytometry. Apply this technique to patients with CGD and the X-linked obligate carriers. The assay has been optimized to improve the detection sensitivity and can reliably detect at the .05% level. This is being applied to the evaluation of CGD patients following allogenic granulocyte transfusions and in CGD patients participating in gene therapy trials.